Transforming dbGaP genetic and genomic data to FAIR-ready by artificial intelligence and machine learning algorithms

dbGaP is a repository for NIH funded projects and it contains many genetic and genomic data.
However, data there are not ready for AI and machine learning applications. This application
proposes methods to address this issue. We have two aims: 1). Develop and standardize
procedures to transfer genetic and genomic data into image like objects and tokenized custom
vocabulary so that the data can be utilized by advanced AI algorithms such CNN, autoencoder
and transformer. To transform genetic data into image, we recode allele dosage value as pixel
intensity and arrange a collection of genetic markers such as SNPs and CNVs into an artificial
image object so that it can be analyzed by CNN algorithms. Genetic markers can also be used
to define haplotypes, which can be tokenized into custom vocabularies for use in NLP models.
2). Use Alzheimer's disease and schizophrenia as case studies to demonstrate the utilities of
transformed data for the discovery and identification of risk variants/genes for both conditions.
We plan to impute genetically controlled gene expression using brain specific eQTLs and
individual genotypes for an AD dataset, and transform the expression data into image objects
for analyses by CNN model with self attention mechanism. For schizophrenia, we plan to use k-
mer tokenizer to break haplotypes into a collection of small haplotype blocks and treat them as
tokens for analyses by NLP models. We use both CNN and NLP models as screen tools to
select promising candidates using the attention weights, and then directly test these candidates
for their association with AD/schizophrenia using logistic regression. Due to the selection effect,
we can dramatically reduce the number of testing, significantly increase our statistical power to
detect risk variants/genes to AD/schizophrenia.

Public health relevance
In this application, we propose methods to transform genetic and genomic data into image like objects and custom vocabulary so that we can apply advanced AI and machine learning algorithms to study genetics and genomics. In the proposal, we plan to use Alzheimer's disease and schizophrenia as case studies to demonstrate how transformed data can be used to identify risk variants to both diseases using convolutional neural network and transformer algorithms.